Word Learning and the Spatial Context of Naturalistic Scenes

Project Summary/Abstract
Language input to children is replete with environmental regularities that they can use to support word
learning. Nevertheless, our understanding of how environmental context affects language acquisition remains
limited because of methodological barriers to approximating real-world dynamics in experimental settings and
theoretical barriers to describing how non-linguistic contexts support inferences about word meanings. This
proposed project takes first steps towards bridging the gap between naturalistic and experimental approaches
to word learning by examining how distinct environments can act as rich source of meaning that learners might
leverage to generate inferences about novel words. It tests the hypothesis that learners can use conceptual
knowledge about what occurs where to help them disambiguate word meanings. For example, a child may not
initially know the word for pancake-flipping instrument, but they may notice that the word “spatula” and the
object [spatula] both occur where food is prepared, and that the object [spatula] is also used to prepare food.
Such conceptual relationships might serve to help learners connect novel words to their referents.
The current project uses two experiments to investigate how learners rely on environmental cues
differently when learning occurs across different levels of contextualization (e.g., in one location versus many
locations), and when it occurs across conceptually distinct environments (e.g., kitchen, bathroom, living room,
bedroom) versus similar environments (e.g., four bedrooms). It is motivated by preliminary work showing that
adults are sensitive to environmental information even when it is not the target of learning, as evidenced by
better learning when words occur in more constrained contexts. Aim 1 will evaluate how contextualization and
the conceptual meaning of different environments affects word learning in children. Aim 2 will evaluate how
contextualization and the conceptual meaning of environments affects word learning in adults differently when
learning takes place on a two-dimensional screen versus in a three-dimensional virtual reality (VR) setting.
By moving beyond mere statistical regularities, this study will 1) reveal the extent to which learners rely
on the conceptual meaning of environments to support vocabulary acquisition, and 2) enable a mechanistic
account of how information in scenes is integrated across domains for linguistic purposes. If environmental
context conveys conceptual meanings from objects and scenes, this opens the door to the possibility that non-
linguistic pathways may be responsible for word learning difficulties in children with language disorders.
Understanding the role of environmental context may shift treatment towards a more holistic approach focused
on the integration of linguistic and non-linguistic knowledge in lieu of a focus only on explicitly linguistic skills.
Indeed, establishing how environmental context benefits vocabulary acquisition may improve our ability to
optimize physical spaces to support learning for all individuals both at home and in school settings.

Public health relevance
Project Narrative Language input to children is replete with environmental regularities, and words occurring in consistent places are learned more easily than words that are more scattered in use. The current project examines the possibility that word learning in easier in consistent places because learners can use the conceptual meaning of distinct locations to help them figure out the meanings of novel words (e.g., the kitchen is a place to prepare food). Understanding the role of non-linguistic information in word learning will support novel approaches to therapy for children who experience word learning difficulty, including those with language disorders.